EFFICACY STUDY OF IRBESARTAN IN HYPERTENSIVE TYPE II DIABETICS

The purose of this investigation is to provide information regarding the safety and efficacy of irbesartan in hypertensive type II diabetics with proteinuria.